Development of a systems pharmacology agent for treatment of bronchopulmonary dysplasia

This Direct to Phase II SBIR Application is responsive to NHLBI Small Business Topics of Special Interest
(therapeutics) of high programmatic interest. Preterm infants are at great risk of developing bronchopulmonary
dysplasia (BPD). BPD leads to a significant impact on lifelong respiratory health. BPD is an oxidative stress-
dependent disease that inhibits alveolarization and induces a combination of other pernicious processes that
results in sustained states of inflammation in the lungs of preterm infants. About 15,000 BPD cases are reported
per year in the US. The costs of caring for BPD patients in the Neonatal Intensive Care Unit (NICU) are over
$350,000 each just in the first months of life. Such costs are over twice the amount required for NICU patients
without BPD. In preliminary studies, we show that N-acetyl-lysyltyrosylcysteine amide (KYC), a novel,
bioengineered tripeptide inhibitor of myeloperoxidase (MPO) toxic oxidant production, is an effective agent for
improving lung growth, increasing weight gain, and improving survival in hyperoxic pups by inhibiting multiple
points of a newly defined destructive inflammatory cycle initiated by supplemental oxygen (S-O2) and the tissue
damage caused by S-O2. Accordingly, the goal of this Direct to Phase II proposal is to perform the preclinical
safety, pharmacokinetic, pharmacodynamic, and preliminary toxicology studies necessary to generate data
required for pre-IND meetings with the FDA for using KYC to treat BPD patients presenting in the NICU. In Aim
1, we will determine the efficacy of IV KYC in hyperoxic rat pups and its pharmacokinetics. Preliminary studies
reveal that KYC has an excellent intravenous (IV) and subcutaneous (SQ) bioavailability in adult mice. Our
previous published BPD studies utilized KYC given to hyperoxic rat pups by the intraperitoneal (IP) route. Aim
1A will be to determine the efficacy of KYC given by the IV route to hyperoxic rat pups compared to IP
administration. We will examine the pups for translational effects of KYC on inflammation and lung development
to confirm published IP administration findings. In Aim 1B, we will determine the pharmacokinetics (PK) of KYC
in rat pups. In Aim 2, we will determine the efficacy of KYC in preterm hyperoxic rabbit kittens. We will determine
the effectiveness of IV administered KYC in the 29-day gestation preterm hyperoxic rabbit kitten model of BPD.
We will study the translational effects on inflammation and lung development as per Aim 1. In Aim 3, we will
perform preclinical toxicology studies of KYC. Repeated-dose general toxicology studies will be carried out in
juvenile rats and beagles. These studies will follow a standard design, with the assessment of clinical signs, body
weight, food consumption, toxicokinetics, clinical pathology (hematology, clinical chemistry, and urinalysis), and
organ weights. With data from Aims 1-3 in hand, ReNeuroGen will be prepared for both a commercialization
readiness pilot program proposal and pre-IND meetings with the FDA.

Public health relevance
Project Narrative Bronchopulmonary dysplasia (BPD) is a severe lung disease that occurs in 10% of all preterm births. About 15,000 BPD cases are reported per year in the US. The costs of caring for BPD patients in the Neonatal Intensive Care Unit (NICU) are over $350,000 each just in the first months of life. Such costs are over twice the amount required for NICU patients without BPD. This application aims to develop for human use a novel drug that improves lung development in animal models of BPD.